Pilot Project Program

PROJECT SUMMARY/ABSTRACT – PILOT PROJECT PROGRAM
The PPP serves the core mission of the Center for Human Health and the Environment (CHHE)
by fostering early-stage investigators; serving as a mechanism to recruit new scientists to EHS
research; supporting innovative research initiatives that are difficult to fund at early stages;
and cultivating multi-disciplinary projects that integrate the Center’s strengths in basic,
applied, clinical, and public health research. Specifically, the PPP supports short-term projects
to explore the feasibility of new areas of study, with a major emphasis on the effects and
potential consequences of environmental exposures on human health as it relates to the five
CHHE thematic research interest areas. Funded pilot projects should lead to the collection of
sufficient data to pursue support through extramural funding mechanisms, especially from the
NIEHS. Consequently, the PPP will be a hub for promoting an expansion of EHS research at NC
State, East Carolina University (ECU), and North Carolina Central University (NCCU). In addition,
the PPP accepts applications between CHHE members and community partners, especially
when they address community issues that align with the Center’s thematic research interests
and the mission of the NIEHS.
Building on CHHE’s prior success, the overarching goal of the PPP in this renewal is to provide
support for high quality individual, collaborative, multidisciplinary, and multi-institutional
research aimed at understanding the adverse impacts of environmental factors on human
health and disease. CHHE PPP aims to foster EHS research in areas relevant to the five CHHE
research interest groups (RIGs), which are: 1) Behavior and Neuroscience, 2) Water and
Emerging Challenges, 3) Genes, Environment and Precision Health, 4) Health and Airborne
Contaminants, and 5) Environmental Health Disparities. CHHE PPP also supports high quality
environmental health research outside of its thematic areas. The PPP has a track record of
supporting high risk/high gain research using cutting-edge techniques and translational
research addressing environmental health concerns. PPP applicants are encouraged to seek
assistance and consultation with CHHE Cores prior to submission. PPP awardees, especially
early career researchers, are supported by the Admin Core’s Career Development Program.
Community Engagement Core (CEC) Co-Directors will work with PPP and CHHE investigators to
identify and connect stakeholders with CHHE members sharing mutual interests in specific
environmental problems. This mechanism will be part of a pipeline that provides opportunities
for partnerships and aids in the development of community-engaged projects.
Through both grant and institutional commitments, CHHE expects to fund 8-10 pilot
projects/year at $25,000/project for single investigator applications and $50,000 for dual
investigator applications. An additional $5,000 will be available for multi-institutional projects
or projects supporting community engagement activities aligning with the NIEHS mission.
CHHE PPP will sponsor at least 1 pilot project/year for community-engaged projects.